PHASE I/II IN CHRONIC HEPATITIS C PATIENTS, FAILED CONVENTIONAL THERAPY

The proposed investigation will determine the safety, efficacy, and tolerability of treatment of chronic hepatitis C with interferon beta in comparison to a currently approved treatment, interferon alpha.